Histone and DNA methyltransferases in optic nerve regeneration

Project summary
Mature neurons in the central nervous system of adult mammals, including retinal ganglion cells (RGCs) whose
axons form the optic nerve, are incapable of regenerating. This presents a major challenge to restoring vision in
patients with optic nerve injury or diseases, such as glaucoma, an optic nerve disease that affects 80 million
people globally. Long-standing works from my laboratory demonstrate that optic nerve elongation is a programed
event during development whose shut-down contributes critically to the failure of optic nerve regeneration.
Potentially, epigenetic modification may reprogram neurons to regain this capacity by reactivating progenitor cell
genes that have been silenced during neural maturation. Methylation, a key epigenetic mechanism carried out
by histone methyltransferases (HMTs) and DNA methyltransferases (DNMTs), is essential in retinogenesis.
Increased levels of methylation and methyltransferases activity is highly correlated with aging and retinal
diseases progression. However, the functional role of epigenetic factors HMTs and DNMTs in RGC
degeneration, or glaucoma in general, is unclear. By examining specific epigenetic changes associated with
RGCs in mouse, we recently detected dynamic expression of a major HMT, enhancer of zeste homolog 1 (Ezh1)
and a key member of DNMTs, that inversely correlate with retinal neuritogenesis and the optic nerve regenerative
capacity of RGCs. Importantly, our pilot study found that pan inhibition of Ezh1 or DNMTs by small-molecule
compounds increased neurite outgrowth in primary RGCs in vitro, and mice carrying selective DNMT deficiency
in RGCs promoted robust axon re-growth in vitro and in injured optic nerve in vivo. We hypothesized that
resetting the developmental epigenetic program induced by Ezh1 or DNMTs promotes the regenerative capacity
of the optic nerve. The hypothesis will be tested in two specific aims: (1) Exploit the molecular events by which
Ezh1 and DNMTs regulate RGC neurite growth in vitro, and (2) Examine the role of Ezh1 or DNMTs in optic
nerve growth in vivo. This study will advance our knowledge about the epigenetic modulation of neuritogenesis,
with the potential of discovering novel therapeutic strategies against neurodegenerative diseases.

Public health relevance
Project narrative Glaucoma, the leading cause of incurable blindness globally, is an age-related eye disease that involves irreversible loss of retinal ganglion cell axons. It is proposed that epigenetic modification may be able to reverse such loss by reprogramming neurons to regain their growth capacity. We recently identified that enhancer of zeste homolog 1 (Ezh1) and DNA methyltransferases (DNMT), two major epigenetic modifiers that deposit methyl groups onto histone and DNAs respectively to regulate gene expression, is strongly linked to RGC axogenesis. This proposed research will explore the functional roles of Ezh1 and DNMTs in the growth and regenerative ability of RGC axons with the vision to offer clinically relevant strategies targeting methyltransferases to rescue RGC axon loss in glaucoma patients.